Administrative Core

PROJECT SUMMARY
The Administrative Core represents the executive, training, coordinating, and oversight component of the
Brigham and Women’s Hospital (BWH) Core Centers for Clinical Research (CCCR). The BWH CCCR, VERITY
(Value and Evidence in Rheumatology using bioInformaTics, and advanced analYtics), leverages the
resources of BWH and Harvard Medical School (HMS) to offer services to the community of clinical
investigators defined by the NIAMS mission, locally and nationally. The services provided by the
Methodology Core and Bioinformatics Core respond to identified needs for better access to a complete
array of clinical research methods organized in a streamlined and readily accessible format. Building on
the success of the prior cycle of funding, the Administrative Core contains an enhanced Enrichment Program
with wide course offering through both face-to-face and virtual distance learning, aiming to train and mentor
pediatric and adult rheumatic and musculoskeletal (MSK) clinical researchers, locally and nationally. The
specific Enrichment Program offerings are informed by our experiences in the prior cycle and survey data from
the Research Community. The overall purpose of the VERITY Administrative Core is to continue to build
and maintain a community of trainees, junior, and senior investigators working toward the common
goal of improving treatment and outcomes of rheumatic and MSK disease. The Administrative Core
provides scientific oversight for all aspects of the Methodology Core and Bioinformatics Resource
Core. These objectives are accomplished through the following Specific Aims: 1. To facilitate and supervise
the scientific and administrative work of the Methodology Core and Bioinformatics Resource Core, ensuring
that the needs of the Research Community are met in an efficient and responsible manner; 2. To train the next
generation of adult and pediatric clinical researchers in rheumatic and musculoskeletal diseases, with an
increased focus on URiM capacity building. During the first 4+ years of VERITY, the faculty trained and
mentored over 40 junior faculty and trainees. The modes of training have included: formal pedagogy through
the biennial VERITY Clinical Research Course and mini-courses; 1:1 mentoring through a robust local and
national program; heavily discounted Core services for junior faculty and trainees; a Pilot & Feasibility grant
program; and a series of seminars with web-based streaming. In sum, the VERITY Administrative Core
provides effective scientific and administrative oversight to ensure optimal use of the Methodology
and Bioinformatics Resource Core services. The Enrichment Program attracts, educates, and mentors the
next generation of clinical researchers to enhance pediatric and adult rheumatic and MSK disease research in
the US. Furthermore, the Administrative Core collaborates with other NIAMS CCCRs to create synergy across
sites improving services for the Research Community.